Multi-scale Computational Modeling Core

SUMMARY
The Multi-scale Computational Modeling (MCM) Core will provide support for SC-TRIMH investigators toward
building a patient-specific and precision-care musculoskeletal system through multi-scale modeling at cellular,
tissue, body levels. Specifically, we will (Aim 1) acquire and maintain the most advanced software tools and
packages to enable SC-TRIHM investigators to perform computational bioengineering modeling at cellular,
tissue, and body multi-scale levels; (Aim 2) tune and customize the set of computational tools and packages so
that the SC-TRIMH investigators can take full advantage of Clemson's Palmetto Cluster to meet their
computational needs; (Aim 3) provide general and project-specific assistances and mentoring to all SC-TRIMH
investigators and their associates, especially those who do not have primary expertise in modeling of complex
problems, with training sessions, workshops and one-on-one hands-on experiences; and (Aim 4) promote the
MCM Core as a leading resource and the “go-to place” for researchers from Clemson University, the southeast
region, FDA and beyond in multi-scale and multi-discipline computational modeling. To do this we will take full
advantage of, and expand the current resources and capabilities of the resources at Clemson University, which
entails Clemson's powerful supercomputing capability – the “Palmetto Cluster” (ranked in the Top 4 among public
institutions in the United States), the Multiphysics Modeling Studio, and the large amounts of patient/specimen
specific data needed for model building at Greenville Health Systems. One major challenge facing the field of
bioengineering is its heavy reliance on the knowledge and investigative approaches developed in traditional
compartmentalized disciplines such as mechanical engineering, materials science, etc. Most of the
bioengineering problems are complex and cannot be easily reduced to sub-problems belonging to separated
disciplines. Bioengineering based on computational modeling offers a unique way to address this challenge. The
MCM Core will strive to provide all necessary support, mentoring and training to SC-TRIMH investigators by
employing our extensive existing capabilities and expertise, as well as further developing them. Depending on
the specific needs of these projects, the services and support will vary from hands-on and technically oriented
modeling assistance, to helping access and utilize the Palmetto Cluster capability to maximal research benefit.
Additionally, the core will provide mentoring and strategic planning to all investigators, especially those who do
not have primary expertise in modeling of complex problems. Aside from building the MCM Core as a unique
resource that will provide essential expertise and infrastructure in the area of multi-scale and multi-discipline
computational modeling of bioengineering problems to support the SC-TRIMH investigators, we aim to develop
this multi-scale computational modeling core into the `go-to' place for researchers from across region, and around
the country and the world for complex computational bioengineering needs.

Public health relevance
NARRATIVE The Multi-scale Computational Modeling (MCM) Core will provide support for SC-TRIMH investigators toward building a patient-specific and precision-care musculoskeletal system through computer simulations at cellular, tissue, and body levels. This core will take full advantage of the current resources and capabilities at Clemson University, which entails Clemson's powerful supercomputing capability, known as the “Palmetto Cluster” (ranked in the Top 4 among public institutions in the United States), the recently established Multiphysics Modeling Studio, and the large amounts of patient specific data available for model building at Greenville Health Systems.